Multi-functional 3D Printed Dental Implants for Preventing Peri-implantitis

Project Summary/Abstract
Peri-implantitis is one of the most common and challenging implant-related oral infections that affect millions of
patients every year. This project aims to develop a multi-functional [antibacterial and bioactive (that can
osseointegrate efficiently)] patient-specific dental implant that can effectively prevent peri-implantitis.
Specifically, we will develop highly tunable silver-doped amorphous magnesium phosphate (AgAMP) bioceramic
particles and incorporate them in a high-performance biopolymer matrix known as Polyetheretherketone (PEEK)
to engineer AgAMP-PEEK multi-functional composite, referred to as Ultra-PEEK. Notably, Ultra-PEEK will be
developed as uniform diameter filaments that can be used in a Fused Filament Fabrication (FFF)-based 3D
printer as a feedstock material to develop high-resolution implants. Feasibility studies show that the 3D-printed
Ultra-PEEK implants exhibit approving mechanical properties, and the Ultra-PEEK implant composition
demonstrates comparable osseointegration properties to clinical standard Titanium implants. Notably, Ultra-
PEEK implants also show promising in vitro antibacterial efficacy. However, refining the implant composition and
3D printing parameters is necessary to yield implants with optimum mechanical, antibacterial, and
osseointegration properties (i.e., with high clinical value). Hence, in the first specific aim, we aim to determine
the processing-structure-property relationships of 3D-printed Ultra-PEEK implants. To accomplish the latter aim,
we will analyze the effect of AgAMP content on Ultra-PEEK’s mechanical properties. We will develop 3D-printed
Ultra-PEEK implants with varying AgAMP content using high-temperature FFF and validate their fatigue strength
per FDA requirements. In the second specific aim, we will determine the infection resistance and
osseointegration properties of Ultra-PEEK implants. The bacterial inhibition capabilities will be initially
determined in vitro using biofilm models against peri-implantitis-associated oral pathogens. Biocompatibility will
be determined using standard in vitro assays. Finally, a well-proven polymicrobial peri-implantitis rodent (rat)
model will be used to determine Ultra-PEEKs’ infection resistance and osseointegration capabilities. Finally, in
the third specific aim, a highly translational peri-implantitis porcine animal model will be used to determine
the implants' infection resistance and osseointegration capabilities by analyzing clinical parameters such
as bleeding on probing, pocket depth, gingival recession, and clinical attachment level compared to
titanium controls. After accomplishing this project, we envision establishing the first-of-its-kind, unique,
antibacterial, and bioactive 3D printed implant that will hinder peri-implantitis incidences for patients needing
tooth implants and relieve patients from the baleful aftermaths of implant-related infections.

Public health relevance
Project Narrative This research will develop a unique multi-functional 3D printed dental implant that will effectively minimize peri- implantitis, i.e., dental implant-related infection incidences for patients needing artificial tooth/teeth. This unique infection-resistant and bioactive dental implant can also be tailored according to patient defects. They will relieve patients from the baleful aftermaths of infections, such as surgical pain, repeated clinic visits for treatment, prolonged recovery time, reliability on antibiotics, and added therapy costs.